Metabolic adaptations to crisantaspase treatment mediated by the pancreatic ductal adenocarcinoma

Pancreatic ductal adenocarcinoma (PDAC) is an aggressive disease without meaningful therapeutic options beyond
the first salvage therapy. Targeting PDAC metabolism through amino acid restriction has emerged as a promising new
strategy, with asparaginases, enzymes that deplete plasma glutamine and asparagine, reaching clinical trials.
Although a Phase 2b clinical trial in metastatic PDAC patients demonstrated that Eryaspase (E. coli asparaginase
encapsulated in erythrocytes) in combination with chemotherapy significantly prolonged progression free survival and
overall survival, the confirmatory Phase 3 trial failed to meet the primary overall survival endpoint of overall. While
amino acid restriction strategies are a promising therapeutic approach, metabolic support from the tumor
microenvironment (TME) and the induction of compensatory metabolic pathways can limit its effectiveness. Pancreatic
stellate cells (PSCs) are a key stromal component of the PDAC TME that have been shown to support PDAC growth
in nutrient-poor conditions through the transfer of metabolites highlighting the importance of investigating
crisantaspase in the context of PSC and PDAC interactions. Moreover, amino acid deprivation promotes activation of
cytoprotective mechanisms, including the amino acid response (AAR) pathway and autophagy, which function to
restore amino acid homeostasis. We recently reported that Erwinia chrysanthemi-derived asparaginase (called
crisantaspase) induced tumor expression of asparagine and serine biosynthetic enzymes in murine PDAC models.
We hypothesize that crisantaspase- mediated induction of autophagy and AAR signaling in both PDAC and PSCs
promotes PDAC resistance to crisantaspase and that targeting these support pathways can restore crisantaspase
sensitivity. To test this hypothesis, we propose to establish the effect of clinically available short-acting crisantaspase
on the metabolic crosstalk between PDAC and PSCs and how autophagy and AAR response pathway induction in
both cell types contributes to crisantaspase sensitivity. Furthermore, we will investigate pharmacological targeting of
autophagy and the AAR pathway to enhance the anti-cancer effects of crisantaspase. Finally, to better recapitulate
real-world PDAC/PSC interactions, we will establish paired primary cultures of human PDAC and PSCs derived from
surgically excised tumors. Completion of the proposed studies will elucidate the mechanisms that PDAC cells can use
to overcome crisantaspase treatment and identify novel targets to improve therapeutic response.

Public health relevance
Pancreatic ductal adenocarcinoma (PDAC) is an aggressive cancer with limited treatment options and a poor prognosis. This project seeks to improve the effectiveness of crisantaspase, a novel treatment that targets tumor metabolism, by identifying and addressing the mechanisms that contribute to resistance against this therapy. The findings from this research could lead to new therapeutic strategies, ultimately enhancing survival outcomes for patients facing this challenging disease.